Bridging the Gap: Understanding Clinician Stigma in Buprenorphine Prescribing and Its Influence on Treatment Decisions and Patient Perspectives in the Veterans Health Administration

Project Summary/Abstract
Amid a national overdose epidemic, treatment rates for opioid use disorder (OUD) remain concerningly
low, indicating significant barriers to care. Veterans experience distinct health disparities, heightening their
vulnerability to opioid use, including their risk for OUD and opioid overdose, yet nearly 60% of Veterans with
OUD do not receive OUD treatment. While medications to treat OUD (MOUD) (e.g., buprenorphine) are highly
effective, use of MOUDs among Veterans is low. Stigma has been identified as a barrier to MOUD treatment,
impacting both treatment decisions and patient experiences. Research on stigma related to MOUD (i.e.,
intervention stigma) has primarily focused on the general population, used qualitative methods, and surveyed
clinicians who don't prescribe MOUD. Additionally, we have a limited understanding of how comorbid
substance use may compound stigma and influence clinicians' beliefs about MOUD and treatment decisions, a
crucial question given the increasing rates of overdoses involving multiple substances. Consistent with NIDA
priorities on stigma reduction, there is a need to further understand stigma factors affecting MOUD treatment
access and utilization among Veterans. This study addresses a critical gap in the literature by conducting
mixed-methods analyses with secondary data using quantitative data from a sample of VHA buprenorphine
prescribers that examined clinician characteristics, attitudes, and prescribing practices and semi-structured
interviews from a sample of Veterans with OUD that explored barriers and facilitators to MOUD. This project is
significant in its goal to identify potential targets for interventions that reduce stigma and increase access to
MOUD treatment for Veterans. This project is innovative in its use of an expansive mixed-methods approach
that captures both clinician and patient perspectives to understand how stigma factors impact OUD treatment.
The proposed study will utilize a patient-centered mixed-method approach to develop profiles of buprenorphine
prescribers based on MOUD intervention stigma factors and explore demographic predictors of profiles and the
association of profiles with specific MOUD treatment decisions across vignettes of different patient profiles of
varying complexity and comorbid conditions (e.g., SUDs) (Aim 1) and qualitatively explore Veteran's
perceptions experiences with intervention stigma and OUD treatment (Aim 2). Proposed work, contextualized
by patient perceptions, will specifically: a) link clinician stigma factors related to MOUD to treatment
approaches and, 2) provide valuable guidance for who stigma reduction interventions may be most needed
and factors to address including both at the individual level and community level. The goal of this proposal is to
provide the Applicant with training experiences that will improve her content area knowledge, analytic skills,
and scientific communication, which are vital to flourishing as an independent researcher. The environment at
the University of Rhode Island, including data analysis software, grant support, and an excellent mentorship
team with content expertise, provide the ideal setting for the successful completion of the proposed project.

Public health relevance
Project Narrative Amid a national overdose epidemic, treatment rates for opioid use disorder (OUD) remain low, with nearly 60% of Veterans with OUD not receiving treatment, despite the effectiveness of medications for OUD (MOUD) like buprenorphine. Stigma poses a significant barrier to MOUD treatment, yet research has not directly explored how stigma factors (e.g., clinician attitudes) impact MOUD treatment decisions, and previous work has primarily focused on the general population and lacks understanding of how comorbid substance use may compound stigma and influence treatment decisions. This mixed-methods approach by analyzing experiences MOUD study aims to address these gaps using clinician stigma factors and prescribing practice alongside Veterans' with MOUD treatment to inform future interventions that reduce stigma and increase access to treatment. a s